Overcoming early childhood caries disease burden through the words of mothers (WOM project)

PROJECT ABSTRACT
Although oral health is an integral part of overall health for pregnant women, studies show that only 23-59% of
women went to the dentist while pregnant. In North Carolina, the Medicaid for Pregnant Women (MPW) program
provides dental services to women during pregnancy. However, dental utilization by low-income pregnant
women in North Carolina ranged from 1–26%. Pregnant women should have regular dental visits to avoid
gingivitis and periodontitis, which are associated with increased risk of pre-eclampsia, preterm birth, and low
birth weight infants. Dental visits during pregnancy are important for the treatment of current issues and for
receiving education on their oral health and their child's oral health. We believe that identifying and addressing
the oral health barriers experienced by this population, as well as creating a welcoming, culturally sensitive
environment, will positively influence pregnant women's own oral health and their children's. To achieve this
goal, we will use a community-based participatory research approach called photovoice. First, we will determine
barriers to maintaining good oral health behaviors and accessing dental care among low-income
pregnant women and mothers of infants. Second, we will determine the perspectives of women's health
care providers/midwives/obstetricians on barriers faced by pregnant women on maintaining good oral
health and identify sustainable interventions that could support them on this behavior. We will partner
with the community to develop options that support family participation in preventive oral healthcare and develop
practical solutions to remove barriers and enable family-level behavior changes that are sustainable. Our ultimate
goal is to have data that will inform the development of a community-engaged oral health program targeting
pregnant women that will aim to improve their oral health and that of their children during early childhood.

Public health relevance
PROJECT NARRATIVE The establishment of oral health in pregnant women can have a lasting impact on their own oral health and their children's through their lifespan. This project will build the infrastructure for future interventions that incorporate the voices of pregnant women to build effective messages for oral health education to prevent oral diseases potentially decreasing the expenses on children's dental treatment. The successful completion of this project will collect evidenced data to develop a preventive program to decrease prevalence of early childhood caries.